Elucidating the role of DNAPKcs in chromosomal break end joining and clastogen

SUMMARY
Kinase inhibitors targeting the catalytic subunit of the DNA-dependent protein kinase (DNAPKcs) are being
developed to sensitize tumors to clastogenic (chromosomal-breaking) agents, such as radiotherapy. The
DNAPKcs kinase inhibitor M3814 (EMD Serono) is in clinical trials, and other new potent inhibitors have been
reported. Elucidating the role of DNAPKcs in the repair of chromosomal breaks is significant because it will
enable the identification of the contexts (e.g. tumor genetic background and treatment regimens) in which
DNAPKcs kinase inhibitors are most effective, and thereby develop biomarkers to predict tumor response.
DNAPKcs has long been recognized as important for promoting radioresistance, and is implicated in the
canonical non-homologous end joining pathway (C-NHEJ), but nonetheless its role in chromosomal break
repair has remained elusive. The goals of the parent grant, and the project in this supplement application, are
to define the role of DNAPKcs in chromosomal DSB repair and clastogen resistance, and thereby support
development of DNAPKcs as a cancer therapeutic target. To this end, our laboratory recently identified a
specific hallmark of C-NHEJ. Namely, we reported that several C-NHEJ factors (i.e. XLF, KU70, and XRCC4)
are required for EJ between blunt-ended DSBs (induced by the Cas9 nuclease) that are joined without causing
insertion/deletion mutations (indels), i.e. for accurate/No Indel EJ. We have been using this hallmark of C-
NHEJ to define the role of DNAPKcs in this process. Regarding the specific project for this supplement
application, the candidate for this application, Ms. Kaela Makins, has found that the factor RIF1 is particularly
important for No Indel EJ in cells treated with a DNAPKcs kinase inhibitor. She will develop these preliminary
findings to 1) test the hypothesis that RIF1 and DNAPKcs synergistically promote No Indel EJ, which includes
development of a RIF1 knockout (KO) human cell line to test this hypothesis, 2) test the genetic interplay
between RIF1 and DNAPKcs for radioresistance, 3) test for effects of RIF1 on DNAPKcs autophosphorylation,
4) examine the interplay of RIF1 and DNAPKcs using double-knockout cell lines, and 5) develop a genetic
complementation assay for RIF1. Her training plan is to develop 1) key research design and experimental
skills, 2) manuscript and grant writing skills, 3) presentation and networking skills, 4) mentoring skills, and 5)
a breadth of knowledge in Cancer Biology. Altogether, this supplement to enhance diversity in health-related
research will further the goals of the parent grant to define the contexts that influence the role of DNAPKcs in
chromosomal break repair and clastogen response, as well as provide comprehensive training for the
candidate Ms. Kaela Makins to develop into an independent and impactful cancer researcher.

Public health relevance
NARRATIVE Chromosomal-breaking agents (i.e. clastogens), including ionizing radiation, remain a cornerstone of cancer therapy; nevertheless, their efficacy could be improved by inhibiting the repair of chromosomal breaks in cancer cells. Indeed, inhibitors of the DNA-dependent protein kinase catalytic subunit (DNAPKcs) are being developed for this approach; but to identify the ideal contexts for using such inhibitors, it is critical to understand the role of DNAPKcs in chromosomal break repair, which is the focus of the parent grant and the project in this supplement application. The proposed studies on this project, and training plan for the candidate Ms. Kaela Makins, will support the mission of the NIH to improve cancer treatments and patient outcomes, and advance the specific goals of in this supplement program to enhance diversity in health-related research.